Local Food Safety Collaborative

1 This proposal, Local Food Safety Collaborative (LFSC), is a collaboration between national and local 2 organizations to provide education, outreach, training, technical assistance to small and mid-size farms 3 and businesses, including diversified, sustainable, organic, and identity-preserved agricultural 4 operations; beginning and socially disadvantaged farmers; small-scale processors; value-added farm 5 businesses; and direct and intermediate supply-chain participants (target audience or local producers). 6 7 National Farmers Union Foundation intends to build its approach off the LFSC Needs Assessment Survey 8 and LFSC Needs Assessment Listening Session Reports of local producers conducted during the previous 9 installment of this award, issued in 2016. During this assessment, Cornell University, with NFUF and 10 other collaborators, designed a survey to better understand a multitude of factors surrounding food 11 safety practices, knowledge, motivations, and barriers among local food producers. Then, using the 12 results of this survey, a series of listening sessions were organized to verify and further clarify needs by 13 providing a forum for food producers to discuss their food safety knowledge, challenges to 14 implementation, and needs for additional resources. 15 16 With these identified needs in mind, LFSC intends to help the target audience understand where they 17 fall within regulatory compliance and connect them with food safety experts to improve their practices. 18 In order to maximize the ability to reach growers and processors, LFSC emphasizes the involvement of 19 farm organizations in partnership with regulators and academic institutions. Listed collaborators will 20 allow the team to utilize a nationwide advocacy and educational network, while teaming with local 21 organizations that work with local producers. Key objectives of the proposal include: 22 23 • Education ? Develop and deliver a variety of educational opportunities to local producers and that 24 meet them where they are. 25 • Outreach ? Outreach to farmers and small-scale processors for increased awareness about food 26 safety compliance. 27 • Training ? Develop a national training plan for local producers, including an alternate curriculum. 28 • Technical Assistance - Provide direct technical assistance to local producers on-farm. 29 • Evaluation ? Evaluate the impact of above objectives to identify best practices, challenges, and 30 lessons learned.

Public health relevance
Local Food Safety Collaborative (LFSC) is dedicated to enhancing the fundamental knowledge of food safety and especially on-farm good agricultural practices of local food producers (farmers and processors) who have a unique place within the Food Safety Modernization Act (FSMA) regulations. By leveraging the results of the LFSC Needs Assessment, previous food safety project experience, and partner organizations’ areas of expertise, this program will provide education, outreach and training; develop an alternate curriculum; and build capacity and infrastructure via technical assistance. LFSC is dedicated to helping local producers advance their food safety knowledge and capacity in order to increase compliance and enable them to continue providing consumers with safe, healthy local food.